A lung cancer vaccine based on exosomes of induced pluripotent stem cells

A lung cancer vaccine based on exosomes of induced pluripotent stem cells
ABSTRACT
A critical challenge in lung cancer research is to develop innovative vaccines to protect against pulmonary
malignancy. Recent efforts to develop lung cancer vaccines have largely failed, probably due to their focus on
inducing immune responses against individual lung tumor-associated antigens. If a lung cancer vaccine targets
multiple antigens present only in lung tumors, but not in normal adult tissues, the chance of success will be
greatly improved. Induced pluripotent stem cells (iPSCs) are reprogrammed from somatic cells and have the
capacity of self-renewing and developing into all cell types of the adult body. It is known that iPSCs and tumor
cells share carcinoembryonic antigens that are absent in normal adult tissues. Lung tumors also contain a
subpopulation of tumor-initiating cells (TICs) with high tumorigenicity and self-renewal capability that contribute
to the resistance to conventional therapies. Exploiting the antigenic similarity between tumor cells and iPSCs,
we propose to thoroughly investigate efficacy of a lung cancer vaccine composed of exosomes from murine
iPSCs expressing granulocyte-macrophage colony stimulating factor (GM-CSF) as an immunostimulatory
adjuvant (iPSC-exo). We hypothesize that iPSC-exo vaccination prevents lung tumorigenesis by triggering
CD8+ T cell-dependent immune responses and eradicating lung TICs. In this grant, we will investigate this
hypothesis in two clinically relevant, immunocompetent murine lung tumor models. Two specific aims are
proposed: 1) Investigate the translational potential of iPSC-exo vaccination against lung cancer; 2) Elucidate
the mechanism by which iPSC-exo vaccination prevents lung cancer. We believe that the success of proposed
experiments will lead to clinical trials of a similar vaccine against human pulmonary malignancy.

Public health relevance
PROJECT NARRATIVE Emerging evidence supports the hypothesis that vaccination with pluripotent stem cells is efficacious at preventing lung cancer, probably by specifically inducing robust CD8+ cytotoxic T cell responses and immunity against tumor-initiating cells (TICs). In this grant, we propose to thoroughly explore the efficacy of an anti-lung cancer vaccine – exosomes of allogeneic murine iPSCs expressing granulocyte-macrophage colony stimulating factor (GM-CSF) as an immunostimulatory adjuvant (iPSC-exo vaccine). We will investigate the efficacies of iPSC-exo vaccination against primary as well as recurrent lung malignancy and evaluate whether TICs are the targets for this vaccination strategy through the induction of robust CD8+ T cell-dependent immune responses.